Interleaved TMS-fMRI for Hippocampal Stimulation: Modeling Dose-Response Relationship in Amnestic Mild Cognitive Impairment

Project Summery/Abstract
Theta burst stimulation (TBS) is a non-invasive brain stimulation technique that has emerged as
a promising therapy for mild cognitive impairment (MCI) and Alzheimer’s disease (AD). However,
little effort has been undertaken to optimize the application of TBS for these populations. Previous
animal in vitro studies have found that TBS could induce long-term potentiation (LTP) in adult rat
hippocampal slices in a dose-dependent manner. The maximum LTP effect was observed after
TBS sessions were repeated three times, with a 60-minute break between each session. The
dose-response curve was flattened when TBS applications did not have adequate interludes. This
points to an array of parameters that must be properly tuned to achieve the desired TBS effects.
The purpose of the study is to investigate the effects of spaced TBS at a superficial brain region
connected to the hippocampus in individuals with amnestic MCI (aMCI). TBS will be applied inside
an MRI scanner interleaved with fMRI to visualize the immediate response to the hippocampal
stimulation. Aim 1 of the study will determine the effects of spaced TBS on memory performance
and hippocampal function in individuals with aMCI. Aim 2 will establish dose-response
relationship of the spaced TBS effect. Thirty-eight individuals with aMCI will be randomly assigned
to one of the two TBS groups: active TBS or sham TBS. We hypothesize that 1) the spaced TBS
protocol will enhance memory function, strengthen hippocampal functional connectivity, and
increase hippocampal activation compared to the sham TBS, and 2) a positive dose-response
relationship of the TBS effect will be observed. By leveraging cutting edge MRI-compatible TBS,
findings of our innovative study may suggest mechanisms of spaced hippocampal TBS in aMCI.
Ultimately, understanding how brain responds to the spaced TBS will enable development of an
optimized TBS therapeutic protocol for individuals with MCI and AD.

Public health relevance
Project Narrative – Public Health Relevance Statement Neuromodulation through theta burst stimulation holds promise in improving memory function for individuals with amnestic mild cognitive impairment who have an increased risk of progression to Alzheimer’s disease. This project aims to maximize response to the theta burst stimulation and represents an important step in the clinical application of theta burst stimulation in the enhancement of memory performance and hippocampal function. Findings of the study may have a sustained and powerful impact on public health by determining the optimal dosing parameters for individuals with amnestic mild cognitive impairment.